COMPARING TWO METHODS OF OBTAINING BLOOD CULTURE SAMPLES FROM NEONATES

This project will investigate two methods of obtaining blood cultures from neonates: the traditional peripheral venipuncture and a method which uses the umbilical vein to obtain the blood culture sample.